CE25-149 - Enhancing Project DHARMA; evaluating a community-based drug checking navigator intervention to prevent overdoses

Fentanyl and xylazine pose new life-threatening risks to people who use drugs (PWUD), particularly in rural
areas such as northern New England. In New Hampshire and Maine, 91% and 78% of overdose deaths in
2023, respectively, were attributed to fentanyl. In Maine, nearly one in ten overdose deaths involved xylazine,
placing it among the states most impacted by xylazine-adulterated fentanyl. Despite the threat posed by
fentanyl and xylazine, PWUD in New Hampshire and Maine have little to no access to drug checking services
to inform drug-related decision-making and thus potentially reduce overdose. In Maine, our existing Project
DHARMA (Distribution of Harm Reduction Access in Rural Maine Areas) team, which includes syringe service
programs (SSPs), has catalyzed the passage of legislation that has made drug checking services available.
However, SSPs are understaffed and the impacts of drug checking services in a rural state like Maine remain
unknown. Therefore, we propose a difference-in-differences (DID) study to develop, implement, and evaluate
an enhanced drug checking navigator (DCN) community-based intervention to prevent overdoses. We will
compare differences in overdose prevalence in Maine, where the DCN intervention will be implemented by
SSPs, to New Hampshire, where the intervention will not be implemented. We theorize that improving access
to community-based drug checking programs will improve PWUD’s knowledge about their drugs, leading to a
change in drug use behaviors, and ultimately cause a reduction in overdoses. Our study includes three aims.
In Aim 1, we will conduct focus groups and co-design workshops with PWUD and SSP staff to ensure the DCN
intervention meets the needs of PWUD and to develop the implementation strategy with tailoring, as needed,
for each SSP. In Aim 2, the SSPs will implement the DCN intervention across seven Maine counties while our
study team rigorously evaluates its effect on county overdose prevalence using a difference-in-differences
design with six counties in New Hampshire serving as the comparison arm. The primary outcome of interest
will be the annual nonfatal and fatal overdose prevalence at county-level. We will also examine several
secondary outcomes that we theorize the DCN intervention may impact such as improvements in safer drug-
use behaviors, linkage to health care, linkage to other SSP harm reduction services, and temporal changes in
the drug supply. Finally, in Aim 3, we will use mixed methods to examine the implementation of the DCN
intervention in order to understand what worked and what did not work with the approach. We will examine
process outcomes such as acceptability, appropriateness, feasibility, fidelity, implementation cost, penetration,
and sustainability. If we demonstrate its effectiveness, this DCN community-based intervention model could
provide critical information on developing similar community-based interventions in other settings, such as in
New Hampshire or other rural areas.

Public health relevance
Project Narrative Fentanyl and xylazine pose new life-threatening risks to people who use drugs (PWUD), particularly in rural areas such as in northern New England. Community-based drug checking services may be an impactful approach to informing PWUD about their drug supply, leading to an increase in safer drug use decision-making and behaviors, and ultimately reducing overdose; but such a strategy has yet to be evaluated. We propose a difference-in-differences study to develop, implement, and evaluate the impact of an enhanced drug checking navigator (DCN) intervention on overdose prevention. The study, implemented by community-based syringe service programs, will compare differences in overdose prevalence in Maine, where the DCN intervention will be implemented, to New Hampshire, where the intervention will not be implemented.